IMMUNOLOGIC CHARACTERIZATION OF SYNOVIAL TISSUE FROM PATIENTS W/RA

Synovial tissues and peripheral blood mononucler cells are obtained from patients with active chronic synovitis, such as rheumatoid arthritis. The analysis of these samples suggests that conditions, such as rheumatoid arthritis, comprise an immunopathologic spectrum. Patients at the polar extremes of this spectrum display consistent phenotypic and funcitonal characteristics. An anergic subpopulation of patients with rheumatoid arthritis has been compared with a clinically similar nonanergic group. Peripheral blood mononuclear cells from anergic patients, in general, exhibited lower T helper/inducer to T suppressor lymphocyte ratios and increased frequencies of HLA-DR bearing T lymphocytes than those from nonanergic patients. In contrast, synovial tissues from anergic patients, in general, had high intensity T helper/inducer lymphocyte infiltration, while the tissues from the nonanergic group was, in general, sparsely infiltrated by lymphocytes. Moreover, synovial mast cell numbers were closely correlated with the intensity of T cell infiltration, i.e., the more dense the T-cell infiltration, the more numerous were the mast cells. Data also suggested that these phenotypic differences are also reflected by cytokine secretion (e.g., T lymphocyte derived chemotactic factor is produced in abundance by synovium from anergic, but not from nonanergic patients). These findings provide insight into pathogenic mechanisms and may result in improved therapeutic procedures.